Mechanisms of T Cell IFNy and IL-17 Production in Juvenile Idiopathic Arthritis

PROJECT SUMMARY/ABSTRACT
Juvenile idiopathic arthritis (JIA) is an autoimmune arthritis in children characterized by chronic joint
inflammation. T helper type 1 (Th1), Th17, and pathologic Th17.1 cells and the inflammatory cytokines
produced by these cells, interferon gamma (IFNγ) and interleukin-17 (IL-17), are implicated in JIA
pathogenesis. A major knowledge gap is to understand how these inflammatory Th cells and cytokines
develop. This proposal outlines a research and training plan focused on studying how IL-17 and dual IFNγ-IL-
17 producing cells inappropriately develop during JIA Th1 differentiation. A goal for these studies is to identify
biologic factors that can be used to improve diagnostic and therapeutic decisions. The investigator conducted
studies that described: 1) polyarticular JIA circulating cells that underwent Th1 differentiation produced high
levels of IL-17 and IFNγ and dual IFNγ-IL-17 producing cells, 2) a JIA patient with a rare loss-of-function
GATA3 mutation exhibited an exaggerated form of this phenotype, and 3) additional JIA patients carry rare
protein-coding mutations in genes important for Th1 differentiation. The proposal’s central hypothesis is that
JIA Th1 differentiation inappropriately produces IL-17 and Th1.17 cells and rare genetic mutations contribute to
this phenotype. The proposed Specific Aims test this hypothesis. Aim 1 identifies the role of novel genetic
mutations from JIA patients in production of IL-17, IFNγ, and Th1.17 cells during Th1 differentiation. Aim 2
identifies the cytokine and STAT signaling pathways that lead to the production of IL-17 and Th1.17 cells
during polyarticular JIA Th1 differentiation. This proposal involves translational studies in human cells using
advanced cytometry, molecular biology, and next generation sequencing. A major focus of this proposal is to
support Dr. Patrick’s development as a physician-scientist. Her career goal is to study the pathogenesis of JIA
in a basic research program and identify biologic factors that generate novel therapeutic targets and improve
diagnostic and therapeutic decisions. She will accomplish this goal through career aims to become an
immunology expert, gain advanced expertise in immunologic techniques, establish proficiency in the use and
analysis of next-generation sequencing, and acquire skillsets to become an independent principal investigator.
The research environment for the proposal is outstanding. Dr. Patrick has full departmental and institutional
support for the development of her research program. Her mentors are immunologists with expertise in the
planned advanced techniques. Vanderbilt has excellent facilities and shared resources for training in these
techniques. Her mentoring team includes experts in immunology, gene regulation, and rheumatologic disease
to guide development of her independent research program. This K08 will support the generation of data and
lead to publications providing insight into the pathogenesis and genetics of JIA and in support of a successful
R01 application.

Public health relevance
PROJECT NARRATIVE Juvenile idiopathic arthritis (JIA) is an immune-mediated chronic disease in which T cells produce high levels of inflammatory cytokines. This study aims to understand how rare genetic variants and abnormal signaling pathways cause JIA T cells to make high amounts of the inflammatory cytokines, interleukin 17 and interferon gamma. These discoveries will identify how inflammatory cells and cytokines develop in JIA with the goal of generating novel therapeutic targets and improving diagnostic and therapeutic decisions.